Targeting Cognitive Control to Improve Physical Activity Adherence in Midlife for Alzheimer's Risk Reduction

Project Summary
Although evidence in favor of physical activity (PA) for reducing age-related cognitive decline continues
to grow, critical issues for the viability of PA to promote cognitive health are persistently low PA adoption
and adherence in the population. Because PA starts declining at middle-age and neurodegenerative
pathologies increasing dementia risk start decades before cognitive impairment, there is a pressing need
to understand how and why middle-age adults are successful at adopting and sustaining PA. Theoretical
and empirical support have identified self-regulatory capacities as critical for acting on our intentions and
plans to be more physically active, however causal evidence testing whether and how strongly self-
regulatory capacities affect PA behavior change is absent from the literature. Therefore, our objective is
to test the causal role of the self-regulation construct, cognitive control, in PA behavior change among
inactive middle-age adults. Based on the Temporal Self-Regulation Theory (TST) for PA behavior
change, we hypothesize cognitive training designed to improve cognitive control will increase the
success of a PA behavior change program, and that training cognitive control with emotionally valenced
stimuli will further increase PA adherence at moderate-to-vigorous intensities. Our predictions are based
on research showing the importance of cognitive control in PA adherence and maintenance, evidence
that negative affective experiences of PA are common and detrimental to future PA initiation and
maintenance, and research supporting the modifiability of cognitive control with adaptive cognitive
training. We test our overall hypothesis with three aims, including a developmental R61 phase (Aim 1) to
develop and refine a computerized training program targeting aspects of motivation, planning, and
cognitive control theorized to promote PA behavior change, followed by an implementation R33 phase
(Aim 2) with a lab-based, randomized controlled trial (RCT) to determine the extent that cognitive control
for emotionally valenced information is a target mechanism for PA behavior change in inactive middle-
age adults. The RCT implemented in Aim 2 will be tested across rural and urban sites to increase
diversity and generalizability of our sample, which forms the basis for (Aim 3) determining moderators of
intervention efficacy for improving PA behavior change. We predict those with poor cognitive control and
high negative affective experiences to moderate intensity PA will benefit most from cognitive control
training targeted to an affective domain for PA behavior change. Our results will be significant by
determining the causal role of cognitive control and affect in sustainable PA behavior change in the
critical period of midlife. Success will culminate in a scalable training program to boost PA adherence,
setting the stage for personalized and accessible strategies for midlife adults to change their course
towards a more physically active lifestyle and a virtuous cycle of sustained cognitive and physical health.

Public health relevance
Project Narrative The public health impact of physical activity during the critical midlife period to slow cognitive aging depends on new insights about how to increase both the effectiveness and sustainability of physical activity intervention programs designed with the heart and brain in mind. Moderate-to-vigorous intensity activity is critical for these benefits, but can be difficult to achieve due to high demands on self-regulatory abilities needed to reverse sedentary habits and mange negative feelings evoked by exercise. The proposed research will develop and test the efficacy of cognitive training strategies designed to improve these self-regulatory capacities for middle-aged adults to adopt and sustain a physically active lifestyle.